Circuit control of motivation to take and seek alcohol

ABSTRACT
Alcohol Use disorder (AUD) is a disorder in which alcohol alters a wide range of neural circuits to cause
maladaptive behaviors across several behavioral domains. Despite the prevalence and cost of this disorder,
treatment strategies are ineffective, especially in preventing relapse. A key feature in some individuals is the
induction of negative affective states when alcohol consumption is ceased. In these individuals, alcohol taking
and seeking is hypothesized to be motivated by negative reinforcement, where individuals continue
consuming alcohol to avoid negative internal states that are triggered by abstinence. While past research has
focused on how abstinence produces negative affective states, the question remains as to how affective
disturbances motivate behavior (i.e. negative reinforcement). To this end, the goal of this proposal to
understand how circuits that control the motivation to avoid aversive stimuli are engaged by alcohol and
associated cues to drive alcohol seeking. At the center of reinforcement is the nucleus accumbens (NAc). The
NAc is a heterogeneous region primarily composed of two non-overlapping cell types: D1 and D2 medium
spiny projection neurons (MSNs) which play complementary roles in controlling motivated behaviors4. While
previous work has implicated D1 MSNs in positive reinforcement, our data show that D2 MSNs respond to
cues that signal negative reinforcement and causally control the motivation to avoid aversive stimuli.
We hypothesize that D2 MSNs are engaged by alcohol-associated cues following withdrawal from chronic
intermittent ethanol exposure (CIE; achieved via vapor inhalation), and drive alcohol seeking.
To address these questions, will use a variety of cutting-edge optical approaches to record from and
manipulate these cells to define the temporal patterns by which they respond to alcohol associated cues and
link this to alcohol seeking following CIE exposure. We will determine how the development of D2 responses to
alcohol-associated cues is predicted by the negative affective states that develop over withdrawal from CIE.
Finally, using patch clamp electrophysiology with channelrhodopsin assisted circuit mapping we will 1) define
how CIE changes glutamatergic drive onto D2 MSNs that are specifically activated by negative reinforcement
(from the prefrontal cortex, thalamus, and basolateral amygdala) and 2) use drugs acutely restricted by
tethering (DARTS) in vivo to prevent glutamatergic drive selectively through AMPA receptors on NAc cells
activated by negative reinforcement and prevent alcohol seeking. Together, we will define how this critical cell
population that controls negative reinforcement drives operant alcohol seeking. This understanding will be
critical to our conceptualization of AUD and why individuals drink following withdrawal.

Public health relevance
PROJECT NARRATIVE Despite the prevalence and cost alcohol use disorder (AUD), treatment strategies are ineffective, especially in preventing relapse. A key feature of AUD is that following long-term drinking, alcohol taking and seeking is motivated by the drive to avoid alcohol’s withdrawal symptoms. This proposal focuses on understanding how the brain controls the motivation to avoid the negative states induced by withdrawal and how we can use this understanding to prevent relapse.